Developing Interpretable Hematology Deep Learning Models For Linking Morphology To Molecular Features In Multiple Myeloma

Abstract
Despite therapeutic advances, multiple myeloma (MM) remains an incurable malignancy with heterogeneous
outcomes. While molecular features like cytogenetic abnormalities and minimal residual disease status provide
important prognostic information, these tests are often unavailable or delayed. In contrast, bone marrow
histology slides are routinely collected and contain rich visual information about disease biology. Deep learning
models have shown promise in analyzing histology across many cancers, but their application to hematologic
malignancies remains limited. Recent advances in foundation models - deep learning systems pre-trained on
vast histology datasets - offer potential solutions, but have been developed primarily for solid tumors. We
hypothesize that bone marrow histology contains morphological features predictive of molecular
characteristics, and that deep learning models can be refined to extract this information. First, we will evaluate
and optimize contemporary foundation models for hematologic histology using a dataset of of over 2000 bone
marrow specimens with matched molecular and clinical annotations. Second, we will apply deep learning
models to identify morphological features in myeloma (using over 200 multiple myeloma cases) that correlate
with established prognostic markers, including cytogenetic abnormalities and minimal residual disease status.
Through novel explainability methods, we will characterize these morphological patterns to provide biological
insights. This work will develop interpretable artificial intelligence tools for hematology while advancing our
understanding of myeloma biology.

Public health relevance
Project Narrative Multiple myeloma is a blood cancer characterized by highly variable treatment responses, making optimal therapy selection challenging for physicians and patients. While molecular testing can help predict disease behavior, these specialized tests are often inaccessible due to cost and logistics. We propose that routine bone marrow tissue samples contain valuable prognostic information that can be systematically analyzed using deep learning methods, ultimately providing accessible tools to support personalized treatment decisions in multiple myeloma care.